Epigenetic Mechanisms of Memory Storage

Project Summary / Abstract
In the hours after learning, the activation of gene expression follows a specific pattern, producing transient
waves of expression needed for long-term memory consolidation. These changes require non-genetic (i.e.,
“epigenetic”) events, including modifications to: DNA-organizing proteins known as histones, the DNA itself,
and the accessibility of DNA to proteins. Additionally, the molecular changes necessary for memory require a
form of RNA-based regulation. In the absence of such changes, the long-lasting regulation of gene expression
during memory storage fails, and this could account for defects in memory that accompany many psychiatric
disorders. Our long-term goal is to define novel epigenetic mechanisms underlying memory storage and
synaptic plasticity by taking advantage of recent advances in our understanding of histone modifications, in the
development of single-cell RNA technology, and in the function of regulatory mechanisms mediated by small
noncoding RNAs. During the previous funding period, we defined a novel metabolic source of acetyl-CoA in the
nucleus and have obtained preliminary data about new forms of histone acylation and crotonylation associated
with spatial learning. We also developed bioinformatic tools to analyze single nuclear RNA sequencing data to
identify neurons activated by learning. We further established the reversal of microRNA (miRNA)-mediated
mRNA silencing as a novel epigenetic means of regulating activity-dependent translation, linking synaptic
activity to translational upregulation of key memory-related targets. These major findings provide the basis of
our proposed experiments that we believe will define the next frontiers in our understanding of the epigenetic
mechanisms of memory consolidation. In Specific Aim 1, we will examine the impact of a novel histone
modification, histone crotonylation, on the epigenetic landscape and gene expression during memory
consolidation. In Specific Aim 2, we will define cell type-specific transcriptional signatures of the hippocampal
neurons during memory consolidation and retrieval. In Specific Aim 3, we will elucidate the microRNA-
dependent mechanisms that regulate long-term memory and synaptic plasticity driven by a microRNA
processing complex. An understanding of these key epigenetic regulatory mechanisms involved in the
consolidation and storage of long-term memories is expected to ultimately lead to the development of new
treatments for the debilitating cognitive deficits associated with psychiatric disorders such as schizophrenia,
autism, bipolar disorder, post-traumatic stress disorder and depression.

Public health relevance
Project Narrative The regulation of specific genes critical to the storage of memories (“memory consolidation”) and changes in neuronal function (“plasticity”) vital for learning are controlled by a number of mechanisms that are not themselves regulated by genetics. We propose to determine the functional roles of such epigenetic processes in memory consolidation and plasticity, and to define the sets of genes that are activated, in individual cells, during memory consolidation. This research promises to provide information that will be critical to the development of novel therapeutics capable of alleviating the cognitive deficits underlying many psychiatric disorders.